Neurodevelopmental adaptations prime olfactory circuits for complex pheromonal communication in the clonal raider ant.

Project Summary
Impaired social communication is a major feature of common neurodevelopmental disorders like autism
spectrum disorder. Nevertheless, cellular mechanisms underlying the development of affected brain networks
remain uncertain, despite the potential to inspire novel diagnostics and pharmacological interventions. Hence,
this represents a key area of need in modern biomedical research. This career development proposal utilizes
an emerging invertebrate model organism, the clonal raider ant, to investigate cellular mechanisms of
neurodevelopment in olfactory brain circuits uniquely adapted for communication.
Ants have evolved a remarkable capacity for chemical communication. Information is encoded by large arrays
of pheromones exuded by dedicated exocrine glands and is received and processed by highly advanced
olfactory systems. With approximately 500 olfactory glomeruli, the clonal raider ant antennal lobe (AL) is more
complex than any other known insect and is evocative of the olfactory bulb in the brain of mammals
(Drosophila have only ~50 AL glomeruli, for reference). Previous work in our lab suggests the evolution of
sociality in ants may have coincided with unique neurodevelopmental logic in the AL supportive of this
complexity. Over three aims, this project investigates early neuronal activity in pupal ant olfactory sensory
neurons (OSNs) and its significance for the normal wiring of brain circuits in adults. First, Aim 1 utilizes
GCaMP-expressing transgenic ants and in vivo two-photon microscopy to characterize spontaneous neuronal
activity in the OSNs of clonal raider ant pupae. In Aim 2, OSN activity is manipulated throughout development
using novel transgenic ant lines and the impact of these perturbations on olfactory circuit structure is
investigated. In Aim 3, optogenetic tools are used to disrupt OSN activity during an isolated period of
widespread synaptogenesis in mature ant pupae and the effect on neuropil volume is examined.

Public health relevance
Project Narrative Human society is supported by neurobiological specializations that enable advanced social cognition and important behavioral phenomena like cooperation and communication. Nevertheless, a mechanistic description of social cognitive networks remains a distant ambition of neuroscience research, despite the potential to enhance public health and support the diagnosis and treatment of nervous system dysfunction. The proposed career development study aims to address this key research gap by investigating the nervous system of a highly social model organism with a simple and tractable brain, the clonal raider ant.